Blending Dentin to Dentin: Biometric Hydrogels for Dentin Tissue Engineering

Project Summary
Dental caries is a major health concern in most industrialized countries, in which most children, young and older
adults have experienced the disease at least once in their lifetime. In recent study (2019) on the impact of oral
diseases on global public health, untreated caries figures as the most prevalent and consequential amongst all
oral conditions, affecting more than 3 billion people worldwide, with strong detrimental effect on quality of life and
high costs for individuals, families, and society. Moreover, caries disease is unequally distributed in populations
with a significant socioeconomic gradient. Although dental caries is essentially a preventable condition, its
prevalence has barely diminished over the last 40 years.
While a definitive approach to prevent and manage dental caries has yet to be found, restorative biomaterials
and techniques remain as the only existing resources for rehabilitation of the caries-affected tooth. The primary
goal of restorative dentistry is to repair tooth damaged structures by replacing them with synthetic materials
aiming at the re-establishment of tooth aesthetics and function. Current restorative procedures fully depend on
effective micromechanical interactions between resin methacrylates and nanostructured organic
macromolecules of dentin (mainly collagen), the bulkiest substrate of tooth demanding substantial repair in dental
rehabilitation schemes. As quoted by several dental material scientists, infiltration of resin methacrylates within
partially demineralized dentin is a type of on-demand tissue engineering.
Nonetheless, creating durable resin-based fillings is still a significant challenge in adhesive dentistry. The NIDCR
2009-2013 strategic plan on tooth-colored resin restorations reported that the average replacement time of these
restorations is only 5.7 years. The major reason for replacement of such restorations has been attributed to
enzymatic degradation of the resin-dentin bonded interface, which ultimately facilitates recurrent caries.
Estimated costs to replace defective resin fillings are in the order of about five billion dollars per year in the US
alone. The overall goal of this proposal is to use modified natural biomaterials to address this matter. This study
will develop hybrid hydrogels by means the functionalization of extracellular matrix (ECM) of demineralized
dentin with acrylamides to produce resin dental adhesives that are less vulnerable to undergo hydrolytic
degradation. In addition, this proposal will pioneer a dental adhesive that is truly biomimetic for endogenous
dentin and, as such, will have the capacity not only repair dental caries lesions, but to regenerate dentin better
than current methacrylate dental adhesives.
This program will offer excellent training opportunities for graduate and professional students, thus providing
scientific support to the next generation of clinicians. Furthermore, while this technology intends primarily
advance dentin bioengineering and rehabilitation, there is a potential to translate our findings to other biomedical
applications where the use of ECM-derivative hydrogels is key to mediate in-situ tissue regeneration.

Public health relevance
Project Narrative Dental caries continues to be the oral health issue that most commonly destroys the dental structures (i.e., enamel, dentin, cementum). Like other preventable noncommunicable diseases, it poses a burden for health public systems in many countries, disproportionally affecting underserved communities. Restorative therapies currently available to rehabilitate the function of caries-affected teeth are fully dependent on the use of resin methacrylates that after about 6 years in-service, or less, must be replaced due to hydrolytic degradation and/or recurrent caries. This study will develop hybrid hydrogels by combining fractions of processed dentin extracellular matrix with hydrolysis-resistant acrylamides to produce unique dental adhesives, which besides being biomimetic for native dentin are also less susceptible to degradation than present restorative methacrylates.